In Vivo Evaluation of Brain Tissue Integrity in Aging Using a Novel Magnetic Resonance Elastography Technique

PROJECT SUMMARY
This project includes both the development of advanced MRI sequences to study brain stiffness as well as
clinical application of this technique to study brain health in an aging adult population. A sensitive method to
establish and reliably detect the point where the progression of Alzheimer’s Disease and other dementias
diverge from normal aging is crucial to developing methods for intervention. Early detection is critical in
lessening the financial burden of these diseases on the US healthcare system. Magnetic resonance
elastography (MRE) is a non-invasive, in vivo, MRI technique which provides information on the mechanical
properties of tissues and is uniquely situated to sensitively provide insight into microstructural tissue changes
that may occur prior to when structural changes caused by atrophy can be detected. The basis of the MRE
technique is that displacements induced in a tissue by an external actuation source can be measured using
phase-contrast MRI, and then turned into high-resolution maps of tissue mechanical properties such as
stiffness. However, this technique is often difficult to widely implement because it requires use of longer scan
times and then further requires specialized equipment to vibrate the tissue. We propose two major
improvements to MRE acquisition and processing to remove these barriers based on a novel sampling
technique and estimation scheme, EDGE (Elastography with Distributed, Generalized Encoding). EDGE
utilizes non-traditional sampling directions implemented in an optimized encoding matrix to collect data much
more efficiently, and be used in a novel algorithm to estimate harmonic displacement fields, together allowing
room for acceleration of acquisition or redundancies to be built into the data for rejection of bad data in the
post-processing step. We also extend this method to intrinsic actuation to capture motion that occurs naturally
from pulsatile cerebral blood flow to provide the motion necessary for MRE mechanical property estimation
(intEDGE), thus removing the need for external hardware and making the scan similar to any other for the
patient experience. We will confirm the validity of these techniques by evaluating differences in brain stiffness
between young and older adults using the traditional MRE method and the proposed EDGE and intEDGE
methods. Success of this project will result in a novel MRE technique that removes barriers to the wide
implementation of MRE as a measure of brain health in aging and aging-related neurological conditions.

Public health relevance
PROJECT NARRATIVE Magnetic Resonance Elastography (MRE) is an in vivo technique for assessing mechanical properties of tissues such as the brain and has many potential clinical applications for the diagnosis and characterization of various aging-related dementias as it is sensitive to microstructural changes that may occur before any macroscopic structural changes occur. However, it is often difficult to implement the MRE technique in clinical and research settings to assess aging and aging-related conditions because of long acquisition times and the need for specialized equipment to cause external vibrations to pass through the brain. This project aims to improve the utility of MRE technology through the implementation of a new MRE acquisition and processing method which uses intrinsic motion of the brain from the cardiac cycle and a novel sampling technique to accelerate data acquisition and improve data quality without the need for specialized equipment.